Cancer Center Support Grant (CCSG)

The Salk Institute is rooted in the notion that exploring the very foundations of life will benefit all. As one of the first Basic Laboratory Cancer Centers to receive the NCI designation in 1973, the Salk Cancer Center (SCC) is a world leader in cancer research, continuing its tradition of pioneering foundational research in cancer biology, gene expression, epigenetics, DNA damage/repair, metabolism, and immunology, as well as training the future generation of cancer scientists. Our central mission is basic discovery — discovery that is the foundation for cancer prevention and therapeutics. The SCC has two Research Programs: Genome Stability, Epigenetics & Aging in Cancer; and Tumor Immunology, Metabolism & Therapeutics. The Programs are supported by seven highly innovative Shared Resources providing SCC members access to cutting-edge technologies, services, and expertise. A recent major restructuring has streamlined decision-making and made leadership more responsive. SCC’s Cancer Research Training and Education Coordination Core is part of the fabric of these efforts, creating a pipeline for the next generation of exceptional cancer scientists and leaders. Through five Strategic Goals, the SCC emphasizes collaborative and translational research while focusing on training the next generation of scientists.

Public health relevance
The Salk Basic Laboratory Cancer Center is a world leader in cancer research, focusing on foundational science in cancer biology and translating discoveries to benefit patients, while training the next generation of cancer researchers. The Salk Cancer Center has two Research Programs: Genome Stability, Epigenetics & Aging in Cancer; and Tumor Immunology, Metabolism & Therapeutics. The Programs are supported by seven highly innovative Shared Resources providing members access to cutting-edge technologies, services, and expertise.